MAPK signaling: gates, oscillators and circadian timing

Project Summary/Abstract
Virtually every aspect of human physiology and behavior is modulated by an inherent 24 hour (circadian)
timing process. At the center of this clock timing system is the suprachiasmatic nucleus (SCN) of the
hypothalamus. A key feature of the SCN clock is the tight, time-of-day, dependent regulation of the MAPK
(p44/42 mitogen-activated protein kinase) pathway. Two examples of this phenomenon are the daily
oscillations in the activation state of the MAPK pathway, and the clock-gated regulation of the photic
responsiveness of the pathway. Importantly, the clock-generated, temporally-delimited, regulation of MAPK
signaling appears to play a central role in SCN timing and entrainment. Further, the daily gating of MAPK
signaling may be an underlying design principal of all oscillator populations, and as such, MAPK rhythms
could have profound and far-reaching effects on a range of physiological processes. Given these implications,
it is surprising that we still know relatively little about the cellular mechanisms and synaptic circuits that
confer circadian control over MAPK activity. Here, we hypothesize that the circadian regulation of MAPK
signaling is an inherent (cell autonomous) feature of SCN cellular oscillators and that this MAPK rhythm is a key
mechanistic building-block by which the circadian clock modulates both basic and complex physiological states. To test
this hypothesis, we propose the following set of experimental goals. In Aim 1, we will identify the cellular and
network properties of the SCN that give rise to the rhythmic regulation of the MAPK pathway. To this end,
we will, A) Determine whether MAPK rhythms are cell autonomous or whether they result from an
intercellular SCN network, and B) Determine the intracellular signaling events that generate MAPK activity
rhythms. In Aim 2 we propose to characterize the molecular, cellular and systems-based mechanisms by which
the SCN clock gates light-evoked MAPK pathway activation. To address this largely unexplored phenomenon,
we will, A) determine when and how the molecular gate opens, and B), test whether the cytoplasmic ERK
scaffold protein PEA-15 serves as the principal circadian gate on MAPK signaling. Of note, we recently
identified PEA-15 as a modulator of MAPK signaling in the SCN, and its capacity to dynamically regulate ERK
signaling makes it an attractive candidate for the gating of MAPK signaling. In Aim 3 we propose to employ a
selective targeting approach to transgenically disrupt MAPK signaling within the SCN core and shell regions
to address the roles of MAPK signaling in A) the generation of circadian rhythms, and B) the entrainment of
the circadian clock. Further, conditional PEA-15 KO and point mutant PEA-15 transgenic mouse lines will be
used to test a model in which PEA-15 phosphorylation leads to rapid ERK dissociation, which we posit to be a
key step in the initiation of light-evoked phase-shifting. Together, these data will provide fundamental new
insights into the relationship between MAPK signaling and the circadian clock, and point to potential ways in
which the dysregulation of clock-gated MAPK signaling could contribute to disorders of the CNS.

Public health relevance
Project Narrative A wide array of physiological and behavioral states are modulated by an inherent 24 hour (circadian) timing mechanism, and the dysregulation of these biological rhythms has profound and long-lasting deleterious effects on human health. Despite the well-known detrimental effects of circadian disruption, it is surprising that we still know relatively little about how this timing process both affects basic cellular functions and modulates complex behavioral states. Here, we will utilize animal models to test whether the MAPK pathway (a key regulator of human health) is a critical conduit by which the circadian clock modulates physiology and health.